Core III: Information Technology Core

PROJECT ABSTRACT
The Information Technology Shared Resource Core (ITSRC) plays a key role in facilitating the important work
of the Pacific Island Partnership for Cancer Health Equity (PIPCHE) by providing infrastructure support for its
research, research education, and outreach activities. The overall goal of the ITSRC is to provide essential
communication infrastructure support to the Partnership in to the order to overcome the nearly 4,000 mile
distance between the partnering institutions. The ITSRC is led by industry professionals experienced in online
infrastructure, multi-platform communication collaborations, and social media. The ITSRC will satisfy the
communication and information technology needs of all U54 projects by providing communications support
(e.g. videoconferencing, synchronous file sharing, whiteboard discussions) between sites, technical assistance
for informatics (e.g., database management), and maintenance of the Partnership websites and other
communication and social media platforms to inform the community about the Partnership, and to disseminate
research findings.